Molecular regulation of sympathetic neuron activity in cardiovascular disease

The autonomic nervous system is a key regulator of the cardiovascular system including cardiac output.
During disease states such as cardiac failure, autonomic input becomes unbalanced such that the
sympathetic branch is overactivated and the parasympathetic branch shows decreased activity. However,
the molecular mechanisms underlying these changes in neuronal activity are largely unknown. Increased
sympathetic activation is characterized by increased plasma levels of neurotransmitters and are
associated with poor clinical outcomes in human patients with heart failure. This includes the primary
neurotransmitter norepinephrine (NE) that acts through beta-adrenergic receptors to increase heart rate
and contractility, as well a 36 amino-acid co-transmitter neuropeptide Y (NPY) that is co-released under
conditions of higher stimulation. We hypothesize that inflammatory signals that are elevated during
cardiovascular disease potentiate NPY trafficking and release, contributing to disease progression.
Although treatments such as the use of beta-blockers can help stabilize or slow disease progression for
patients with heart failure, currently disease progression cannot be reversed in most cases. Thus,
understanding the molecular changes that underly the dynamic regulation of sympathetic neurons will
enable the development of novel therapeutic interventions. We recently developed a novel imaging
technique, optical pulse-chase axonal long-distance (OPAL) imaging, that enables the visualization of
axonal trafficking of low-abundance proteins such as ion channels with single-molecule resolution. Using
this and other imaging techniques, we propose to investigate the alterations to NPY trafficking in cardiac
sympathetic neurons from neonatal mice cultured in compartmentalized microfluidic chambers. We will
investigate the molecular motors and trafficking machinery involved in the long-distance axonal transport
of NPY-containing vesicles, including Rab-GTPases and kinesin motors. Elucidation of this pathway will
provide targets of opportunity for therapeutic interventions for conditions such as cardiac failure.
Additionally, we propose to investigate the dynamic upregulation of cardiac sympathetic neurons in
response to inflammatory agents (inflammatory cytokines or byproducts of inflammation), using alterations
to NPY vesicular trafficking as measure of neuronal activation.